Small Molecule Inhibitors of the Inflammatory Cytokine Oncostatin M

PROJECT SUMMARY/ABSTRACT
This project will synthesize and study small molecules inhibitors (SMIs) that bind to and inhibit signaling of the
inflammatory cytokine, oncostatin M (OSM) as part of a long-term program to generate an FDA-approved drug
for early protection against breast tumor metastasis and other OSM-associated diseases. In 2021, more than
281,000 new cases of invasive breast cancer are expected to be diagnosed in the United States. The five-year
survival rate is 99% for patients diagnosed with localized disease but drops to 27% for those with distant
metastases, underscoring a need for therapeutics that protect against the early stages of metastasis, when
intervention could be most beneficial. Relevant to this proposal, OSM signaling promotes many metastatic-
related events, including an epithelial to mesenchymal transition and tumor cell detachment, migration, and
invasion. Importantly, OSM signaling is associated with a poor prognosis for breast cancer patients.
Breast cancer patients with high levels of tumor tissue OSM correlated with a significant decrease in survival
compared to those with low OSM levels. It was also determined that serum concentrations of OSM from both
non-metastatic and metastatic breast cancer patients was significantly higher than levels in serum from healthy
individuals (3.8-fold and 4.9-fold, respectively). For this proposal, preliminary experiments used a high
throughput computational screen of ~1.65 million compounds for binding to OSM. Those compounds with the
best predicted binding properties were tested for in vitro inhibition of OSM signaling. Two SMIs were identified
as lead compounds for this proposal. The central hypothesis guiding the proposed experiments is that
structural optimization based on lead SMIs, facilitated by knowledge of important binding interactions,
will result in enhanced inhibition of OSM signaling. To test the hypothesis, two specific aims are proposed:
1) Design and synthesize a focused library of small molecule inhibitors of OSM based on the SMI-10 and SMI-
26 scaffolds and 2) Identify optimal lead SMIs that suppress OSM signaling in cells and display minimal cellular
toxicity. In Aim 1, the NMR solution structure of an SMI/OSM complex will be solved and then combined with
computational modeling to develop a structure-activity model that will be used to design and synthesize new
SMIs. In Aim 2, SMIs will be prioritized based on high binding affinity, high in vitro inhibition of OSM-mediated
signaling pathways in several breast cancer cell lines, and low cellular toxicity. The end goal of the project is to
identify new compounds with nanomolar binding affinity to OSM and improved inhibitory activity. The proposed
research will assist in fulfilling the critical need to develop novel treatments for metastatic breast cancer—often
described as an “incurable” disease. Since OSM has been linked to other cancers and inflammatory-related
diseases (e.g., sepsis, rheumatoid arthritis, and cystic fibrosis), this research lays the groundwork for a new class
of anti-inflammatory drugs.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH Despite new drugs, as well as improved screening and detection methods, the survival rate for breast cancer patients with distant metastases remains a dismal 27%. Therapeutics targeting early stages of metastasis, when intervention could be most efficacious, are sorely needed. Our long-term goal is to develop a drug that blocks the action of oncostatin M (OSM)—a protein implicated in the early stages of breast cancer metastasis and in other diseases.